DIALS: supporting structural biology through open source diffraction processing software

Project Summary/Abstract
X-ray crystallography is a powerful tool for determining the atomic positions of proteins, used by researchers at
synchrotrons and X-ray free electron lasers. Typically, the crystal is exposed to X-rays, which diffract and are
collected on a detector to create diffraction patterns. These patterns are processed by software designed to
seek out weak signal on the images and create datasets from which the protein structure can be solved.
The DIALS diffraction data processing package is a mature product produced in collaboration between
LBNL and Diamond Light Source (UK) that has primarily been supported in the US by research funding. DIALS
is used at a number of synchrotrons world-wide for regular processing of user datasets and has been used at X-
ray free electron lasers for fast processing of large datasets collected at hundreds to thousands of images per
second. The program allows fast feedback of data quality when incorporated into automated processing that
allows users to quickly make decisions about beamline operation and experimental direction. This has allowed
researchers to produce high-impact structures in general biological fields, including human diseases such as
COVID-19 and malaria, and energy research such as photosynthesis.
This proposal would create a US R24 National Resource for the DIALS diffraction data processing
package. The Resource would move DIALS funding in the US from primarily R01 research funding to a
combination of separate research funding and operational funding from this proposal. The operational funding
would be to support codebase optimization, maintenance, and refactoring, a build-and-release schedule, and
new robust and adaptable user interfaces. Further, it would provide user outreach and training, both for general
users, and through on-site training for beamline scientists to help with software integration into existing pipelines.
The end result will be a well-maintained and documented software package used at synchrotrons and
XFELs for routine data analysis without user intervention, and robust support for difficult cases.

Public health relevance
Project Narrative Human health and disease is governed by the cellular and molecular processes of life and detail down to the atomic structure of individual proteins is often required to understand the mechanisms that control disease progression and to design drugs and other therapies such as vaccines to combat them. X-ray crystallography is one of the prime technologies used to generate high quality structures, generated from crystallographic data collected at large US facilities like synchrotrons and X-ray free electron lasers. The DIALS National Resource will support software for the processing of crystallographic data in automated pipelines that will accelerate the discovery of new treatments and improve health outcomes.